Increasing Diversity in Hematology: Training for Underrepresented Students

Project Summary/Abstract
There are few women and underrepresented minorities (URM) entering into the fields of hematology
and pediatrics as well as positions of leadership. It is critical that more underrepresented hematology
researchers are trained to better understand, identify, and reduce health disparities in the field and study
diseases that are relevant to underrepresented communities, such as sickle cell disease and thalassemia, to
improve outcomes.
We have developed an innovative, multidisciplinary training program in nonmalignant
hematology with faculty mentors who have unique expertise and experience training students. The
goal of this R25 application, “Increasing Diversity in Hematology: Training for Underrepresented students,” is
to recruit underrepresented high school graduates and local community college students to Stanford University
to 1) obtain an introduction to clinical aspects of nonmalignant hematology; 2) participate in didactic lectures
and laboratory experience in hematology research, 3) be exposed to ethics in research; and 4) explore career
development options. Given the declining number of underrepresented translational and basic researchers in
hematology, a training program in hematology will be critical to fill the pipeline and ultimately increase the
number of underrepresented leaders in hematology.
In this application, we seek funding for 5 recent underrepresented high school graduates and 5
underrepresented community college students each year to spend 8-weeks during the summer with faculty
who have expertise in mentoring underrepresented students. Students will have the opportunity to perform
research in one of the 30 expert faculty mentors’ laboratories. Trainees will be selected from a pool of >200
eligible high school graduates from cities throughout the country and >1400 students from 26 local community
colleges surrounding Stanford University. The funding will support the students’ salaries and living expenses.
The students will participate in a curriculum consisting of lectures, workshops, and research seminars.
Lectures will focus on introduction to hematology and various research techniques. Career development
workshops for trainees include writing scientific abstracts, giving presentations, ethics, and preparing posters.
Students will also receive “hands on” experience with appropriately matched mentors and their trainees, e.g.
postdoctoral fellows, based on the students’ interests. There will be a poster symposium at the end of the
program. The Program Directors and Internal Advisory Committee will evaluate the program annually. The
External Advisory Committee will review the R25 program every year and meet with the Program Directors,
Internal Advisory Committee members, and students. The R25 program will be evaluated by the student
participants every year. We will utilize the strengths of Stanford University to recruit underrepresented
students to the hematology, including the breadth and depth of investigators across many disciplines, to train
future leaders in the hematology.

Public health relevance
Project Narrative Women and minorities are underrepresented among the leadership in pediatrics and pediatric subspecialties, including nonmalignant hematology. In this R25 application, we propose to develop a program focused on hematology to recruit recent underrepresented high school graduates and community college students to receive hands-on laboratory experience with experienced faculty mentors, introduction to the field of hematology, career development workshops, scientific presentation and writing skills. This program will help to fill the pipeline to develop future underrepresented researchers in hematology.